2025 Epigenetics Gordon Research Conference and Seminar

Epigenetics refers to heritable changes in phenotype not caused by changes to the DNA sequence. Epigenetic regulation is critical for normal cellular functions, including growth, development, and transmission of information across generations. Conversely, epigenetic dysregulation is associated with abnormal development, infertility, and disease. Epigenetic memory can be mediated by a variety of mechanisms, including DNA modifications, non-coding RNAs, histone variants, histone tail modifications, higher-order chromosomal structures, unique protein structures, and possibly other, yet to be discovered, processes. The objectives of the 2025 Epigenetics Gordon Research Conference (GRC) are to present a scientific program that brings together leaders in the field of epigenetic research working in varied model systems and to promote the careers of young investigators. The preliminary program includes speakers at a variety of career stages, ranging from early career investigators to senior leaders in the field. The program is balanced among speakers using a wide variety of models, including humans, mice, worms, fish, flies, yeast, protozoa, and flowering plants, with attention paid to both mechanisms and impact in the contexts of development and disease. The GRC program is designed to include significant dedicated time for networking and discussions. To promote exposure for early career scientists, the main scientific program will include short talks chosen from abstracts and additional micro talks in the form of poster previews. The 2025 Epigenetics Gordon Research Seminar will precede the GRC. This short student and postdoctoral scholar-focused meeting will provide additional opportunities for trainees to present their work, develop peer networks, and gain mentoring from select senior scientists. Together, the GRC and GRS programs will create a venue for cross-disciplinary, and innovative, science necessary to advance the field of epigenetics.

Public health relevance
Epigenetics refers to heritable changes in phenotype not caused by changes to the DNA sequence. Epigenetic dysregulation is associated with abnormal development and disease. The 2025 Gordon Conference on Epigenetics will bring together researchers studying epigenetics in varied organismal systems across all career stages, providing a venue for advancing the field of epigenetics through the sharing of cross-disciplinary, and innovative science.